Defective mitochondria-lysosome contact formation and tethering in disease

PROJECT SUMMARY
Lysosomes and mitochondria are essential organelles for maintaining neuronal homeostasis, and defects in their
function and dynamics have previously been linked to multiple neurodegenerative diseases. In contrast, whether
these two organelles undergo bidirectional crosstalk to contribute to disease pathogenesis is not well understood.
Mitochondria-lysosome contact sites allow for this bidirectional regulation to modulate their network dynamics,
motility and function. Thus, investigating the dynamics of mitochondria-lysosome contacts may provide new
insights into their regulation and their roles in the etiology of neurodegenerative disorders. This research project
uses advanced microscopy techniques to elucidate how defects in mitochondria-lysosome contact tethering
dynamics and formation may contribute to neurodegenerative diseases. Importantly, these studies will help to
highlight new cellular pathways contributing to neurodegeneration in different neurological disorders.

Public health relevance
PROJECT NARRATIVE Multiple neurological diseases are linked to defects in mitochondrial and lysosomal function, but their underlying mechanisms leading to disease pathogenesis are still not completely understood. This project investigates the role of mitochondria-lysosome contact sites and their contribution to neurodegeneration. Importantly, elucidating how mitochondria-lysosome contact sites drive disease is essential for highlighting the mechanistic pathways involved in different neurological disorders.